Lipid Antigen Presentation as a Driver of T2D Inflammation

PROJECT SUMMARY
Substantial research effort has uncovered a critical role for chronic inflammation in the development of insulin
resistance, a hallmark of Type 2 Diabetes (T2D). Even with this discovery, no successful anti-inflammatory
therapeutics have been developed, and research has stagnated with a focus on characterizing adipose tissue
inflammation in mouse models of T2D. Importantly, the initiator of chronic inflammation in T2D remains
unknown. Type 2 Diabetes presents with autoantibodies against a wide array of self-proteins, but protein
screens for antibody reactivity have not discovered initiators of T2D inflammation. Remarkably, not all
autoantigens in T2D are protein. We have identified lipid autoantigens in T2D that have been completely
overlooked, likely due to the proteins which present lipid antigen, Group 1 CD1 molecules, not being expressed
in mice. This lack of expression has left a gaping hole in our understanding of lipid antigens in immunological
homeostasis and disease, especially T2D. To remedy this issue, we will use transgenic mice which express
human CD1 molecules and in vitro models of human immune responses to understand lipid-mediated immune
function in T2D. The long-term goal of this proposal is to establish a new scientific direction with the broad
long-term purpose of understanding the role of lipids in pro-inflammatory responses, T2D, and autoimmune
diseases. This proposal tests the overarching hypothesis that lipid antigen presentation is a key mechanism by
which chronic inflammation in T2D is initiated. This innovative and novel investigation of lipid antigen
presentation in T2D combines use of human blood samples, transgenic and humanized mice, single cell RNA
sequencing, multiparameter cytokine analysis and flow cytometry, coupled with computational methods that
allow for a systems biology approach to antigen discovery and hypotheses testing. In research Area 1, we will
assess lipid antigen dependent activation of T cell responses. We will use humanized mice and human blood
samples to interrogate the impact of these lipid antigens on T cell function in vitro (CD1 tetramer loading) and
in vivo (high fat diet). In research Area 2, we will target lipid antigen presentation to prevent and treat T2D. The
capacity of neutralizing antibodies targeted against group 1 CD1 molecules and lipid autoantigens to inhibit
pro-inflammatory cytokines secreted from human immune cells and to prevent and treat disease in transgenic
mice will be assessed. In research Area 3. Lipid autoantigen discovery in T2D will be performed with a novel
3D printed lipid microarray for antibody profiling. This proposal has the potential to redefine T2D as an
autoimmune disease driven by lipid antigen presentation and completely change the strategies for
management of disease and therapeutic development. Outcomes of this proposal will allow for the
identification of specific inflammatory pathways that can be targeted for disease treatment.

Public health relevance
PROJECT NARRATIVE This proposal will increase our understanding of how the immune system causes disease when it incorrectly recognizes and responds to self-molecules as a threat. By providing understanding of autoimmunity to lipids or “fats” the outcome of this proposal has the potential to redefine Type 2 Diabetes as an autoimmune disease. This will provide new strategies for management of Type 2 Diabetes and new targets for therapeutic development.